Characterizing human exposure to microplastics during pregnancy

Global plastic pollution is a significant environmental and public health concern. Plastic production has
increased since the 1950s, reaching approximately 368 million metric tons in 2019. Approximately 60% of all
plastics ever produced are disposed of, leading to pervasive contamination of our ecosystem with microplastic
particles. Microplastics are a concern for public health given their resistance to degradation, presence in air,
food and products relevant to human exposure, and demonstrated ability to cross cell membranes. Human
exposure via inhalation and ingestion is unavoidable with recent evidence-based estimates suggesting humans
intake tens of thousands of microplastic particles annually, or on the order of several milligrams daily.
Understanding the extent to which microplastics are absorbed is a critical next step in evaluating their
relevance to human health. The overarching aim of this research is to translate methods that have been
developed for measuring microplastics in environmental samples and marine tissues for use with human
biospecimens. Specifically, by leveraging the relatively accessible placenta, we propose an approach to
measure and characterize microplastics in tissue collected from the general population of pregnant people. We
will also investigate sources of exposure, including modifiable lifestyle factors, as well as sources of
contamination present in the labor and delivery room and during sample processing. The proposed research
will leverage existing infrastructure from the N
(NYU CHES), an ongoing prospective birth cohort designed to study prenatal exposure to endocrine disrupting
chemicals on a range of perinatal and child health outcomes. Maternal urinary concentrations of bisphenol and
phthalate chemicals will also be measured during pregnancy. This will allow us to examine patterns of joint
exposure to chemical plastic additives and plastic particles. In sum, we anticipate results from this research will
provide critical insights on the extent to which humans are exposed to microplastics. This information may
significantly alter our view of plastics as inert particles that pass through the human system and lead to a
reassessment of the risks posed by microplastics exposure.

Public health relevance
Microplastic contamination of the environment is ubiquitous with human exposure likely occurring though air, drinking water, food, and personal care products. Microplastics can be absorbed across cell membranes and may pose significant risks to human health. The proposed research will develop methods for measuring and characterizing microplastic exposure among the general pregnant population, which in turn will allow us to begin understanding sources of exposure and investigating human health risks associated with exposure.